Core A: Administrative Core

Administrative Core Abstract
The Administrative Core of the Southern and Central Africa International Centers of Excellence
for Malaria Research (ICEMR) will build on the success of the Southern Africa ICEMR. Over the
past six years the Administrative Core of the Southern Africa ICEMR established strong
personal, management and financial relationships with each of our seven partner institutions in
four countries, including Macha Research Trust, the Tropical Diseases Research Center and
the University of Zambia in Zambia, the Biomedical and Research Training Institute and
National Institute of Health Research in Zimbabwe, Université Protestante au Congo in the
Democratic Republic of Congo, and the University of Witwatersrand in South Africa. These
relationships took years to develop and mature and will form the foundation for the
Administrative Core of the Southern and Central Africa ICEMR.
The Administrative Core will provide the leadership, guidance, administrative support, financial
management and oversight to ensure the efficient resource management and success of the
Southern and Central Africa ICEMR. The Administrative Core's mid- and short-term goals are to
ensure that resources are managed efficiently and the planned research activities are
coordinated, tracked, reported and completed within the proposed timeline. The long-term goals
of the Administrative Core are to ensure that the Southern and Central Africa ICEMR makes
substantial contributions to regional malaria control and elimination through the research and
capacity building of the three Research Areas and the Data Management and Biostatistics,
Spatial Sciences and Parasite Genetics Cores.